HFH-MSU CSRN ACCrual Enrollment and Screening Site

Metropolitan-Detroit based Henry Ford Health (HFH) has over 20 years of experience in the successful conduct of multi-site cancer screening and prevention clinical trials research. As an integrated health care delivery system, our cancer screening trials experience includes, electronic health record identification and engagement of at-risk populations, recruitment and long-term retention of research participants, and comprehensive follow-up of abnormal findings. This experience includes successful recruitment for the NCI Prostate, Lung, Colorectal, and Ovarian Cancer (PLCO) trial and National Lung Screening Trial (NLST). More recently, HFH has successfully enrolled patients in the Connect for Cancer Prevention cohort study. HFH includes seven hospitals, 41 ambulatory clinics, the Henry Ford Medical Group (HFMG) and Cancer Institute (HFCI), and the HFH-Michigan State University Health Sciences Center (HFH-MSU HSC). For over 50 years, HFMG physicians have provided care for the Community Health And Social Services (CHASS) Center, a Federally Qualified Health Clinic. The HFCI treats over 14,000 cancer patients annually. The HFH Department of Public Health Sciences, with over 250 faculty and staff, with significant experience in conducting externally funded clinical, epidemiological and health services research, will be the homebase for our multi-disciplinary team which has experience in brain, breast, colorectal, head and neck, lung, lymphoma, and prostate cancer as well as patient reported outcomes. HFH-MSU HSC also has world-class basic-science research programs developing new cancer screening technologies. We will leverage these existing resources to: 1) conduct a Vanguard pilot study to determine the most effective methods for recruiting and retaining a general population of participants in MCD screening trials, 2) continually improve existing workflows for follow-up of participants with positive findings and establish long-term infrastructure for conducting high quality pragmatic cancer screening trials and, 3) establish collaborative relationships with the Coordinating and Communications Center and Statistical and the Data Management Center that lead to impactful clinical trials which use the most promising new and emerging cancer screening technologies and utilize high-quality and efficient patient-centered data collection and management strategies. The HFH-MSU ACCrual Enrollment and Screening Site, with our large population and investigators experienced in multi-site cancer screening and pragmatic clinical trials, will help launch the Cancer Screening Research Network into this new frontier in cancer screening.

Public health relevance
Cancer is the second leading cause of death in the U.S., and less than 1 in 4 new cancers are estimated to be detected by screening, although screening improves outcomes. HFH-MSU will establish a cancer screening research recruitment hub that engages a generalizable population of our catchment area and will conduct real-world clinical trials to advance cancer screening in the U.S.